The role of senescent cells in dysregulating immune responses and pathogen control

SUMMARY
The association between advanced age and impaired resistance to infections is well known, but poorly
understood. The current COVID-19 pandemic is a clear example of the vulnerability of the elderly to SARS-
CoV-2 infection as well as many other pathogens. Considerable research efforts have shown that components
of both the innate and adaptive immune systems show signs of dysfunction as we age, with signs of both
immunodeficiency, including reduced innate response and poor induction of adaptive immune memory, and
immunopathology including an exaggerated “cytokine storm”. However, while aspects of age-related changes
in immune cells have been explored in depth, the focus has been on defining the nature of dysfunction within
cells of the immune system itself, rather than investigating the potential role of other cell populations in
dominantly compromising immune homeostasis and immunological response to pathogens. Also, although the
increase in immunosenescence with age, defined by cell surface markers for immune cell exhaustion, has
been examined, the extent of cellular senescence in immune cell populations with age and pathogen exposure
remains undefined. Our recent findings indicate that senescent cells (SnCs), including senescent immune
cells, can exert a “bystander” effect on immune cells, provoking immunological dysfunction through secretion of
inflammatory factors, including cytokines and chemokines, termed the “senescence-associated secretory
phenotype” (SASP). We demonstrated that SASP factor production is increased when SnCs or mice containing
SnCs are exposed to pathogens or microbial products that induce innate immune activation. Exposure of old
mice to normal microbial experience (NME) housing resulted in 100% mortality compared to no mortality in
young mice. However, reducing the senescent cell burden in aged mice before or following pathogen exposure
reduced the spread of senescence, the cytokine storm and overall mortality. These results suggests that SnCs,
acting at least in part through SASP factors, can increase peripheral senescence and immune dysfunction
following pathogen exposure. Moreover, viral infection itself drives senescence, termed virus induced
senescence, in mice and humans. Using mouse models in which cellular senescence is induced specifically in
immune cells, we also demonstrated that senescent immune cells drive immunological dysfunction and
secondary senescence and pathology in non-lymphoid tissues. Thus, our overarching hypothesis is that
senescent cells, including senescent immune cell types, dominantly compromise innate and adaptive immune
cell homeostasis in both lymphoid and non-lymphoid organs and reactivity to pathogens. Importantly, we also
hypothesize that these adverse effects can be reversed by SnC elimination with senolytics, providing a new
therapeutic strategy to restoring immune function in the aged. We propose to test these hypotheses in our
PPG application entitled “The role of senescent cells in dysregulating immune responses and pathogen
control”, consisting of three collaborative projects and three integrated cores.

Public health relevance
NARRATIVE As we age, we accumulate “senescent” cells which have a detrimental effect on various organs and tissues, including the immune system, which limits our ability to fight off infections. In this proposal, a team of experts on the biology of aging and immune responses to pathogens combine forces to determine which populations of senescent cells are responsible for these effects, the components of the immune system that they compromise – and how these detrimental effects can be reversed by elimination of senescent cells, using defined and novel therapeutics.